Determining the Origins of Nonclassical Class I molecules through Molecular and Functional Approaches

SUMMARY
Sharks are members of the oldest class of living Vertebrates with adaptive immunity based on immunoglobulin,
T cell receptors, and the major histocompatibility complex. Eight class I lineages have recently been uncovered
by the Flajnik lab, the classical class I (UAA) and seven nonclassical lineages (UBA to UHA). Unexpectedly,
two of these MHC-linked shark nonclassical class I (Class Ib) molecules show striking similarities to the human
nonclassical class I molecules CD1 and HLA-E. Preliminary data on genetics, expression, and sequence
similarity strongly in the Flajnik lab suggest that UFA is the orthologue of CD1. Structural modeling and in silico
biophysical analyses in the Adams lab are consistent with UFA’s clear similarity to CD1, revealing a strongly
hydrophobic binding site. The second shark class Ib molecule, UDA, is predicted to bind peptides like classical
class I, yet it is monomorphic, single-copy, and has properties similar to mammalian HLA-E/Qa-1.
We will biochemically define UFA and UDA ligands and elucidate their structures. We will express and purify
recombinant versions of UDA and UFA for biochemical analysis including ligand elution and preparation of
tetramers to identify the shark cells recognizing these nonclassical class I molecules. Highly purified forms of
recombinant proteins will be used for structural analysis through X-ray crystallography. Using in-house
technologies, we will generate nanobody binding reagents to these proteins for structural analysis and also
complement the antisera and monoclonal antibodies already generated for tissue-expression analysis. By in
situ hybridization and antibody/nanobody staining we will define UDA/UFA cellular expression and examine
their upregulation in cells under stress. UDA and UFA tetramers will reveal which lymphocytes interact with
UDA/UFA and, with single-cell analysis, the adaptive and/or innate receptors that interact with them. We will
perform biochemical analysis of shark primary cells to characterize UDA/UFA biosynthetic pathways.
In this proposal, therefore, we will combine the expertise and experience of the two investigators, Martin
Flajnik, who has studied the genetics, biochemistry, and function of the shark immune system for 35 years and
generally the evolution of adaptive immunity, and Erin Adams, a structural biologist with deep knowledge of the
human class I system and evolutionary biology. In summary, we hypothesize that CD1 and HLA-E analogues
arose at the Big Bang of adaptive immunity 500 million years ago, suggesting that peptide-binding by the
classical class I, lipid-binding by “CD1,” and a peptide-binding by a jack-of-all-trades “HLA-E-like” nonclassical
class I were significant features in the earliest adaptive immune system.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Study of the evolution of the immune system permits an view of those characteristics of immunity that are vital for defense in all animals, including humans, versus those features that are “primitive” or specific to particular species. Our research in comparative immunology gives an overall view of immune molecules, such as the major histocompatibility complex (MHC) molecules, that are required to combat infectious diseases and cancer and avoid autoimmunity. We have detected MHC molecules in sharks, the oldest animals with adaptive immunity, that are likely the forerunners of their human counterparts. We will examine the structure and function of these molecules to gain insight into their functions in humans.